Baylor College of Medicine - Mendelian Genomics Research Center (BCM-MGRC)

PROJECT SUMMARY
The proposed Baylor College of Medicine Mendelian Genomics Research Center (BCM-MGRC) builds on the
extensive discoveries and infrastructure established in the Baylor Hopkins Center for Mendelian Genomics.
This research program is nested within the Department of Molecular and Human Genetics at BCM and will
benefit from an extensive collaborative research infrastructure which includes, the Human Genome
Sequencing Center, the Undiagnosed Diseases Network Clinical Site, the Undiagnosed Diseases Network
Model Organism Screening Center, Baylor Genetics diagnostic laboratory, and the Baylor Knockout Mouse
Program. Notably, each of these programs has established their own national and international collaborations.
A phenotypically and ethnically diverse, international cohort of ~15,000 individuals and families with
challenging-to-diagnose rare disease conditions (those unsolved by routine clinical studies such as exome
sequencing) and who are re-contactable and consented for broad data-sharing will form the basis of the BCM-
MGRC research program. The Center will integrate novel methods of genomic data analysis, data sharing
across networks, implementation of newer genomic sequencing technologies, and methods for molecular and
organismal phenotypic interrogation of prioritized candidate disease genes and variants. The existing Data
Lake infrastructure will integrate with the Mendelian Genomics Data Coordinating Center (MGDCC) and AnVIL
to share key deliverables including genomic and phenotypic data, case metadata, and a BCM-MGRC-
developed Genomic Medicine Toolbox. As a fully integrated Mendelian Genomics Research Center, the BCM-
MGRC will inform development and delivery of an algorithm for solving the unsolved that will tackle complex
molecular mechanisms in the rare and common disease research space, with seamless integration of
anticipated discoveries to support clinical diagnostics and the generation of molecular floorplans from which to
develop precision therapeutics.

Public health relevance
PROJECT NARRATIVE This proposal describes the integration of a Mendelian Genomics Research Center (MGRC) at Baylor College of Medicine in Houston Texas. It builds on past successes of rare disease research programs at Baylor, including the 9-year Baylor Hopkins Center for Mendelian Genomics, and leverages a long tradition of rare disease discovery, translational research, and basic science research that are each internationally recognized components of a collaborative research framework within the Department of Molecular and Human Genetics. We will develop a Genomic Medicine Toolbox and Comprehensive Genomics approach to study challenging rare disease cases with a goal to identify the genetic causes of human disease and seamlessly integrate these findings into clinical care.